Optimization of small molecule immunomodulators as combination therapy for IBD

PROJECT SUMMARY/ABSTRACT:
Despite the availability of current biologics, such as anti-tumor necrosis factor (anti-TNF), anti-integrins,
anti-interleukins, and small molecules such as tofacitinib, the rates of primary and secondary treatment failure
remain high in inflammatory bowel disease (IBD). This highlights the unmet need for the identification of
rational combinations of therapies for IBD with complementary mechanisms of action. Dual targeting of cluster
of differentiation 28 (CD28) and inducible T cell costimulation (ICOS), closely related costimulatory molecules
that play partially overlapping roles in the pathogenesis of IBD, has revealed remarkable success as a potential
therapeutic strategy for IBD as well as other inflammatory diseases. However, dual CD28/ICOS blockade is
currently restricted to protein-based therapeutics associated with unwanted immunogenicity and an increased
risk of adverse events (AEs). In comparison to therapeutic proteins, small molecules will minimize the
immunogenicity risk and enable better management of AEs based on their amenability for pharmacokinetic
optimization. However, there are no small molecules in existence that target ICOS or CD28. To fill this gap, we
have developed an innovative platform, Small Molecules from Antibody Pharmacophores (SMAPs), that can
identify small molecule inhibitors of immune cell receptors with high binding affinity and selectivity. Our SMAPs
platform is based on utilizing cocrystal structures of immune cell receptors with antibodies (Abs) in building
pharmacophore maps from clusters of key interacting residues of Abs with immune cell receptors to identify
small molecules that function as Ab-mimetics. Building on our successful work in drugging immune cell
receptors with small molecule inhibitors, we propose to perform preclinical validation of small molecule-based
dual CD28/ICOS inhibition as a therapeutic strategy for IBD based on small molecule CD28 and ICOS
inhibitors identified from the SMAPs platform. We hypothesize that small molecule-based dual CD28/ICOS
inhibition will result in improved therapeutic outcomes in preclinical models of IBD in comparison to single-
targeted CD28 and ICOS small molecules. We will test our hypothesis and attain our objective via the following
specific aims: (1) optimization of small molecule CD28 inhibitors, followed by validation using biophysical
screening and cell-based assays, (2) assessment of the pharmacokinetic profiles of the optimized CD28 leads,
followed by preclinical validation of small molecule-based dual CD28/ICOS blockade using clinical samples
from IBD patients as well as a mouse T cell transfer model of chronic colitis. Collectively, the proposed
investigations have the potential to identify clinically translatable CD28 inhibitors that can be used in
combination therapy for IBD with small molecule ICOS inhibitors. Successful completion of this work will
enable the initiation of Investigational New Drug (IND)-enabling studies for the optimized therapeutic leads.

Public health relevance
PROJECT NARRATIVE: Current therapeutic approaches for inflammatory bowel disease (IBD) have reached a plateau in the rates of response and/or remission. Overcoming this plateau requires the identification of rational combinations of therapies with complementary mechanisms of action. This work is focused on the preclinical validation of small molecule-based dual CD28/ICOS blockade as a new therapeutic strategy for IBD.